Lung-derived complement in pneumonia

PROJECT ABSTRACT
The objective of this R01 proposal is to investigate the function of lung-derived complement proteins and harness
their activities to mitigate the severity of pneumonia. Complement proteins C3 and Factor B (FB) comprise an
early arm of the host immune response. They are primarily derived from the liver and function in the circulation
by killing pathogens such as bacteria. However, our recent work has demonstrated the importance of local C3
expression in lung epithelial cell survival during stress. This proposal focuses on an emerging role for lung-
derived FB, a ligand for C3, in reducing excessive tissue damage in the setting of an acute bacterial pneumonia.
Our goal is to determine how FB promotes pulmonary host defense. We will investigate sources of FB in the
lung and establish its putative protective effect relative to C3. A major hurdle for investigating tissue-specific
roles of complement has been the limited availability of models and assays. We have developed novel transgenic
mouse models and functional assays that distinguish the roles of liver- and lung-derived complement proteins,
and specifically identify the role of lung-derived FB in pneumonia. Our mouse models are supplemented with
data from in vitro human models that demonstrate the role of FB to protect against stress-induced epithelial cell
death. Additionally, CRISPR-induced deletion of cell-derived complement proteins suggests active
internalization of exogenous complement proteins. These combined results support our central hypothesis that
lung-derived FB promotes host defense by mitigating epithelial cell death. This proposal will test our
hypothesis by achieving two Specific Aims. Aim 1 compares global FB-deficient, targeted liver FB-deficient, and
lung epithelial cell-derived FB-deficient mice to assess how lung-derived FB mitigates acute bronchopneumonia
severity and cell death. We also will assess if augmenting FB in the lung using pharmacological and gene delivery
approaches protects against pneumonia. Aim 2 analyzes whether lung-derived, intracellular FB activity mitigates
cell death in vitro by leveraging a combination of human primary lung epithelial cells and FB-deficient cells to
dissect the molecular and biochemical mechanisms responsible for complement function in the lung. The
proposal integrates knowledge of pulmonary complement activation, intracellular complement protein trafficking,
and structure-function relationships with gene therapy, cell imaging, proteomics, and CRISPR screens to
determine how lung-derived FB promotes epithelial cytoprotection during stress. These approaches are
independent but complementary for investigating the immunobiological role of lung-derived FB in mucosal barrier
protection of the lung. The proposed work is important because understanding how the early host immune
response modulates tissue damage is essential for designing and implementing urgently needed, new therapies
for pneumonia. Thus, we will assess how lung-derived FB facilitates host defense at the site of infection and
promotes tissue resilience. These efforts will help our long-term goal of developing a novel host-focused therapy
for pneumonia, thus aligning with a priority area of the NHLBI Working Group Report on pneumonia research.

Public health relevance
PROJECT NARRATIVE Severe pneumonia is characterized by an increased bacterial burden, exaggerated host immune response, and cellular damage in the lungs, and is a leading cause of death worldwide. There is an urgent need to better understand host defense mechanisms in the lung, with the goal of yielding new therapies to improve pneumonia treatment. Our proposal directly addresses this need by investigating and employing Factor B — a complement protein that is an important part of the host immune response for killing pathogenic bacteria — to reduce the morbidity and mortality associated with pneumonia by leveraging its ability to protect the lung.